Neuronal quality control and neuroprotection in tauopathies

Dendritic simplification and synaptic loss represent major structural correlates of dementia in Alzheimer’s
disease (AD) and frontotemporal dementia (FTD). Mutations in the microtubule-associated protein tau are a
major cause of FTD and increase the risk of developing AD. Mutations in valosin-containing protein (VCP)
have also been linked to familial FTD. In the prior project period, we discovered that dendritic calcium
dyshomeostasis, dysregulated mitophagy and altered protein phosphorylation contribute to dendritic
shrinkage in several models of neurodegeneration. We also discovered a novel interaction between VCP and
the neuroprotective kinase PTEN-induced kinase 1 (PINK1). VCP is a multifunctional protein implicated in
protein degradation, vesicular transport and Golgi remodeling, and these functions are mediated by distinct
VCP cofactors. Based on preliminary data, we hypothesize that PINK1 interacts with VCP to prevent tau-
mediated dendritic shrinkage. We will utilize primary rodent cortical neurons and human iPSC-derived
neurons to study quality control mechanisms that contribute to neuroprotection against tau-mediated
degeneration of dendritic arbors and spines. We will also assess the neuroprotective potential of upregulating
PINK1 signaling in vitro and in vivo. Completion of these studies will reveal how proteins implicated in different
neurodegenerative diseases function together to protect against tau-mediated neurodegeneration.

Public health relevance
Mutations in the gene encoding the protein tau cause frontotemporal dementia and/or increase the risk of developing Alzheimer’s dementia. Tau plays important roles in brain cells (neurons) regulating the cytoskeleton, which is essential for formation and maintenance of the communication network that underlies neuronal function. We have discovered a novel neuroprotective pathway involving two proteins whose gene mutations contribute to frontotemporal dementia and Parkinson’s-related dementia. This proposal focuses upon understanding the mechanism(s) and neuroprotective potential of this pathway in patient-derived neuronal cells and a mouse model.